CRCNS: Computational modeling to predict afferent firing to deep pressure touch

Deep pressure touch can be pleasant and calming, although sometimes intense. It is often experienced in
interpersonal touch, such as a hug, and is commonly used in manual therapy and massage to relieve
musculoskeletal pain. Understanding the neuronal mechanisms underlying chronic musculoskeletal pain
is a key health concern. Physical therapists commonly use deep pressure touch in their patients with
musculoskeletal pain. Deep pressure touch activates different types of mechanoreceptors in skin,
muscles, joints, and fascia. This project will investigate how deep pressure touch is encoded by peripheral
neural afferents - to elucidate how individual subtypes respond to such manipulation, as well as how they
work together as a population. The longer-term goal is to uncover correspondences with the encoding of
tissue stiffness and tension, giving rise to musculoskeletal discomfort, including myofascial pain. The main
objective of this project is to develop computational stimulus-response models of firing in
mechanosensitive afferent subtypes to deep pressure touch in humans. In comparing model predictions to
afferent firing, obtained via microneurography before and after soft tissue manipulation, or massage, this
effort will seek to attribute changes to tissue mechanics and/or neuronal mechanisms. The proposed
methods combine microneurography recordings from human peripheral nerves, bodily physiological
responses, and perceptual judgments, with computational models of time-series relationships between
tissue deformation and neural firing, as well as computer vision tracking of tissue deformation.
Microneurography is highly informative about human peripheral nerve activity, but limited by the problem
of sparse sampling, thus a computational approach is vital to fill in gaps at individual afferent subtype and
population levels. This project focuses on recording from the peroneal nerve, which projects widely
throughout the lower leg, in particular the front and lateral sides of the calf, and the upper foot, which are
sites highly relevant to musculoskeletal pain. From a clinical standpoint, the anterior of the lower leg is
implicated in shin splits, the lateral posterior of the lower leg is tied to sprained ankles, and the posterior of
the foot and calf are tied to calf strain and Achilles tendinosis. These conditions are frequently addressed
via soft tissue manipulation. Overall, the results of this work seek to uncover novel, fundamental insights
into human somatosensation, and impact non-pharmaceutical treatment of musculoskeletal pain.

Public health relevance
Deep pressure touch is experienced in interpersonal exchanges, and is used in manual therapy and massage to relieve musculoskeletal pain. This project will investigate its encoding by peripheral neural afferents to elucidate the response characteristics of distinct subtypes. We will develop computational models of afferent subtypes to deep pressure touch, comparing predictions to measured firing, obtained in human microneurography, and attribute changes to tissue mechanics and/or neuronal mechanisms.